Dynamics of Emotion Regulation, Trauma, and Grief Among Those Impacted by the World Trade Center Attacks

PROJECT SUMMARY/ABSTRACT
The September 11th, 2001 World Trade Center (WTC) attacks resulted in extensive mental health challenges
for survivors, including post-traumatic stress (PTS) and grief due to traumatic bereavement. Effective emotion
regulation (ER) is crucial for recovery, but traumatic events can impair self-regulation, complicating survivors'
ability to manage their distress effectively. This study is part of a broader effort aimed at enhancing ER and
mental health outcomes among those affected by the WTC disaster.
Utilizing Ecological Momentary Assessment (EMA), the study will identify distinct, momentary profiles of ER
difficulties (e.g., non-acceptance, modulation challenges, lack of emotional clarity) and emotion-focused coping
strategies (e.g., rumination, suppression, reappraisal) among WTC survivors experiencing varying levels of
PTS and prolonged grief (PG). The study’s goals are to: (1) employ multilevel latent profile analysis of EMA
data to uncover group patterns in momentary profiles of ER difficulties and coping strategies and their
associations with PTS and PG severity; (2) explore how these momentary profiles relate to emotional intensity,
thereby elucidating mechanisms of emotion dysregulation; and (3) validate these group patterns of momentary
profiles by examining their connections to PTS, PG, functioning, and quality of life in post-EMA and 1-week
follow-up assessments. The study recruits participants from the WTC Survivor Grief Study (WTCSGS),
prioritizing individuals with elevated PTS and PG symptoms. By identifying these patterns and their
implications for PTS, PG, and quality of life, the research will inform the development of a targeted mobile
health intervention aimed at improving ER difficulties and emotion-focused coping strategies, supported
through future R01 funding.
Dr. Rice, with published research in emotional coping and bereavement, will expand his skills in EMA and
intensive longitudinal data analysis. Conducted at a leading trauma-focused research center and supported by
experts in ER, grief, and trauma, this project provides an ideal environment for his professional growth. The
study aligns with NIOSH’s objectives to improve life quality for individuals facing chronic conditions and
multimorbidity among WTC survivors.

Public health relevance
PROJECT NARRATIVE This research aims to improve public health by enhancing strategies for emotion regulation among individuals affected by the World Trade Center (WTC) attacks, who experience varying levels of post-traumatic stress and prolonged grief. By identifying specific emotion regulation profiles, the study aims to develop tailored interventions that address diverse coping needs, ultimately improving mental health outcomes and quality of life for this population. This initiative supports the WTC Health Program’s objectives by aiming to enhance the quality of life for the 9/11 survivor community, providing lasting public health benefits.